BIOMARKERS OF COLORECTAL CANCER PROGNOSIS

Aim of study is to determine whether expression of any of the Mucin, Ploidy or proliferative markers reliable identify the recurrence risk of patients with Colorectal cancer.